Burden and signatures of somatic mutations in genomes of healthy individuals.

Somatic mutations accumulate over the lifetime of an individual due to both genetic and environmental factors.
It is becoming evident that somatic genome changes are associated with a host of pathologies including
cancers. Sequencing genomes of different cancer types suggested that mutation loads vary between cell
types and across the body. The variations have been associated with differential exposure to DNA damaging
agents and the replicative potential of the cells. In addition, mutation loads due to DNA damaging lesions
would also be dependent on the ability of the cells to repair damage in an error-free manner. However, the
mutation loads attributable to environmental and intrinsic factors across cell types in healthy individuals are not
known. Also, it is not known how polymorphisms within DNA repair genes compromise repair efficiency and
alter the mutation landscape in cells exposed to environmental DNA damage as well as in unexposed cells.
The goal of this proposal is to determine the extent of somatic genome changes within the body and in different
individuals and to examine the mechanisms that contribute to this variability. To address this goal, I will
explore the following aims. In Aim1, I will directly analyze the impact of DNA repair polymorphisms associated
with cancers on DNA repair capacity using orthogonal systems. Using plasmid-based host cell reactivation
assays, I will test repair efficiency in lymphocytes with homozygous minor (mutant) or major (wild-type) alleles.
I will also determine if these mutant human genes increase mutation and recombination rates in yeast and
human cells upon exposure to exogenous DNA damage and during unchallenged growth. In Aim2, I will
determine the role of deleterious single nucleotide polymorphisms (SNPs) in DNA repair genes. Mutations
leading to loss of a functional MBD4 glycosylase, have been shown to increase CT changes in CpG
dinucleotides in cancer genomes. I will test if SNPs that are predicted to be deleterious to the MBD4 protein
also increase mutation loads and altering signatures in somatic cells from healthy individuals. In Aim3, I will
estimate mutation loads in different cell-types isolated from the same individuals from different body sites. I will
assess the contributions of mutation signatures associated with known environmental and endogenous
mutagenic sources to mutation loads in the samples. The completion of the studies in this proposal will
provide me with expertise in cell culture, genetic manipulation of human cell lines and bioinformatics, paving
the way for a successful career as an independent researcher.
Significance: These studies will increase our understanding of the interplay of environmental and genetic
factors that determine somatic mutagenesis. These results are important for understanding the susceptibility
of individuals to cancers and other diseases associated with somatic mutagenesis, and in designing individual-
specific disease prevention strategies.

Public health relevance
Somatic mutations that accumulate in an individual’s body reflect the exposure to environmental and endogenous mutagens, and the DNA repair efficacy of the tissue. This proposal will investigate the burden of mutations attributable to environmental or endogenous processes in different body sites of healthy individuals, and the influence of DNA repair defects on altering the DNA repair efficiency, mutation loads and signatures in cells. Investigating mechanisms underlying mutagenesis in healthy humans is important to understand susceptibility of individuals to diseases associated with somatic genome instability.